The Cdk5/35 Kinase

Cyclin-dependent kinase 5 (Cdk5) is a fascinating and enigmatic enzyme necessary for neuronal migration,
synapse development, and synaptic homeostasis. To date, a large body of literature also supports the role of
Cdk5 in numerous phenotypes associated with neurodegenerative disorders, including Alzheimer's disease
(AD). Cdk5 is not catalytically active unless it is associated with a regulatory activator, such as p35 or p39. We
and others showed that p35 can be cleaved by calpain under neurotoxic conditions, which leads to the
generation of the p25 peptide. Various transgenic p25 mouse models exhibit neurodegeneration phenotypes
such as Tau hyperphosphorylation, increased amyloid beta (Aβ), neuroinflammation, synaptic loss, neuronal
loss, and memory impairments, demonstrating that the activity of the p25/Cdk5 kinase can be neurotoxic. In
our last grant period, we created a mouse model harboring a calpain-resistant version of p35 (the Δp35KI
mouse), and found that blocking p25 production abolished AD phenotypes in vivo. In this application, using the
Δp35KI mouse model, we aim to determine the role of p25 generation in Tau-mediated neurodegeneration, as
well as its role in neuroinflammation mediated by microglia. Furthermore, using genome editing in human
induced pluripotent stem cells (iPSCs), we will determine whether p25 generation mediates AD-related
pathology, including amyloid and Tau pathology, synaptic deficits, DNA damage, epigenetic dysregulation,
endosome defects, and neuronal survival in human neurons. The overall hypothesis to be tested in this
application is that p25-mediated Cdk5 dysregulation plays key roles in AD-like neurodegeneration.

Public health relevance
Current treatment approaches for Alzheimer's disease (AD) and other age-related neurodegenerative disorders, have led to failed drug trials, discouraged researchers, and an increasing sense of desperation in a vulnerable aging population. In combating neurodegenerative disease, it is imperative that we understand the multiple pathologies that lead to brain dysfunction, which include neuroinflammation, in addition to amyloid and Tau pathology, and synaptic dysfunction. In the current application, we explore the role of aberrant p25/Cdk5 signaling in both neuroinflammation and Tau pathologies, in novel mouse models as well as neural cells derived from isogenic lines of patient-derived induced pluripotent stem cells (iPSCs).